Training in Advanced Heart Disease Research

The Smidt Heart Institute (SHI) at Cedars-Sinai Medical Center (CSMC) is applying for the second competitive
renewal of its postdoctoral Advanced Heart Disease Research Training Program. The objective of this program
is to provide outstanding team-mentored training in either basic biomedical, translational or health services
research to six postdoctoral fellows (3 per year x 2 years). The goal is to provide trainees with the necessary
skills to develop independent and productive academic careers in cardiovascular science. We seek to ensure
that all our trainees, be they PhDs, MDs, MD/PhDs or equivalent, develop an in-depth knowledge of the basic
science underpinning clinically relevant problems in cardiovascular medicine, as well as a comprehensive
understanding of rigorous study design, appropriate methodology, and expert technical execution of basic and
clinical studies. This not only provides clinical investigators with the skills they need to properly test hypotheses
generated at the basic science level, but also informs basic scientists about the clinical aspects of disease in
order to stimulate clinically relevant state-of-the-art investigations in the laboratory. Our training program’s areas
of research focus include Cardiac Biology, Arrhythmias, Vascular Biology and Atherosclerosis, Regenerative
Medicine, Transplant Immunology, Cardiovascular Imaging, Women’s Health, Community Health,
Implementation Science, Precision Medicine, Artificial Intelligence, Proteomics, and Genetics. The Training
Program takes full advantage of the unique strengths of CSMC, the largest private teaching hospital west of the
Mississippi, which has a longstanding commitment to translational research and to serving the local community.
The SHI houses the largest adult heart transplant program in the world, performed an NIH-funded first-in-human
trial of cardiac-derived stem cell therapy, and has attracted many NIH-funded basic and translational
investigators. Some of these share joint appointments in other CSMC units, which include the Regenerative
Medicine Institute, Biomedical Imaging Research Institute, Advanced Clinical Biosystems Institute and the
Departments of Biomedical Sciences, Medicine, and Pathology. Trainees receive an intensive research
experience in a focused area of investigation, augmented by a formal curriculum that includes both basic and
clinical seminars, instruction in grant and manuscript writing, biostatistics, methodology, and ethics. Courses are
provided by the Department of Biomedical Sciences, the CSMC Clinical Scholars Program, and a multi-campus
NIH CTSA-supported Center for Translational Science Institute (CTSI, includes CSMC, UCLA, Harbor-UCLA,
and Charles R. Drew University). The CTSI provides our trainees with privileged access to project seed funds,
additional courses in clinical research design, methodology and biostatistics, UCLA degree programs in public
health and clinical research, and tools for conducting the entire range of studies from bench to bedside to
community. In summary, we have designed a program that provides in-depth training in critical areas of
cardiovascular science within an environment that champions translational research and clinical excellence.

Public health relevance
The Smidt Heart Institute at Cedars-Sinai Medical Center in Los Angeles is renewing its Institutional Training Grant to support its Advanced Heart Disease Research Training Program. The objective of the program is to provide outstanding team-mentored training in basic biomedical, translational, and health services research to both PhDs and MD-scientists in order to provide them with the necessary skills to develop independent and productive academic careers in cardiovascular science. These future leaders of medicine will be well-equipped to develop new, more effective treatments for diseases of the heart and blood vessels such as heart attack, heart failure, high blood pressure, and sudden death.